Identifying factors associated with prostate cancer progression and survival in African American men: The RESPOND Cohort

African American (AA) men have a >80% higher incidence and are more than twice as likely to die from prostate cancer (PCa) than white men. The reasons for the high burden relating to poor outcomes of PCa among AA men are largely unknown. RESPOND is a nation-wide and comprehensive effort to understand PCa in AA men, with research focused on the role of stress, environmental factors, care and treatment, inherited susceptibility, tumor somatic genetics, the inflammatory tumor microenvironment, as well as the integration of these factors in the diagnosis of aggressive disease. AA men, diagnosed with PCa between 2015 and 2020, have been sampled and recruited from cancer registries in 7 states (California, Georgia, Louisiana, Michigan (Detroit Metropolitan area), New Jersey, Texas, and New York). The RESPOND cohort includes >12,500 AA men with PCa who completed a baseline survey, >7,600 who provided saliva/germline DNA and tumor samples obtained for >3,400. Over the next 5 years, we will leverage the RESPOND recruitment infrastructure and research expertise to update comorbidities, treatment, lifestyle behaviors, area-level data, as well as to obtain information on PCa oncologic outcomes including disease progression/recurrence (P/R) and mortality. Long-term follow-up of this cohort is essential since the development of progressive disease may take several years after diagnosis. These data will be used to address a number of scientific questions and hypotheses aimed at understanding key genetic and non-genetic factors and their inter-relationships that contribute to disease P/R and survival in this high-risk population. In Aim 1, we will examine factors related to access to health care and their relationship to PCa, P/R and survival as well as patient-reported outcomes. In Aim 2, we will investigate the effect of area-level factors and modification by chronic exposure to life-course stressors on PCa aggressiveness, P/R and survival. In Aim 3, we will evaluate the impact of lifestyle factors, comorbid conditions and genetic risk factors on PCa, P/R and mortality. Lastly, in Aim 4, we will leverage deep learning approaches applied to histopathologic images to improve prediction of PCa P/R and survival in AA men. Each aim addresses a distinct research domain (access to care, environment/stress, lifestyle and genetic factors and tumor features), yet, when studied together in a single cohort, scientific synergy is gained and a far more comprehensive picture of the major factors that contribute to PCa, P/R, and PCa survival in AA men. We expect these findings to have broad reaching significance and address numerous challenges in the clinical management and prevention of P/R in AA men, and ultimately improve health outcomes in all men. Furthermore, we expect RESPOND to become an invaluable resource for advancing our understanding of the intersecting multilevel factors contributing to prostate cancer outcomes.

Public health relevance
The overarching goal of this project is to uncover factors that contribute to poor outcomes for prostate cancer in African American men. To address this goal, we propose to leverage a large, national, population-based cohort study (RESPOND) comprised of 12,500 African American men with prostate cancer identified through nine SEER and NPCR U.S. cancer registries. Over the next five years, we will continue to enhance the RESPOND cohort through additional measurement of exposures and outcomes to facilitate translational research that addresses critical scientific questions and hypotheses that have been suggested to contribute to prostate cancer outcomes in African American men, those being access to health care (Aim 1), area-level factors (Aim 2), modifiable lifestyle factors, co-morbidities and genetics (Aim 3), and histopathologic-based risk prediction (Aim 4).